Improving Glycemic Management in Patients with Type 1 Diabetes Using a Context-aware Automated Insulin Delivery System

Project Summary
Automated insulin delivery (AID) systems offer substantial opportunities for helping people with type 1 diabetes
(T1D) to improve glucose control and lower HbA1c. However, the AID has only shown a benefit during the
nighttime when meals, exercise, and stress do not significantly challenge the AID. Furthermore, hypoglycemia
(<70 mg/dL) remains a common occurrence in people with type 1 diabetes and continues to occur even in the
setting of AID, particularly with exercise. Integrating context awareness into an AID has the potential to
improve glycemic time in range (70-180 mg/dL) during the daytime and reduce and possibly eliminate
hypoglycemia. Contextual information can include inferred food intake, insulin dosing, inferred exercise type
and duration, as well as movement patterns. An AID can be designed to recognize contextual patterns that
relate to poor glycemic responses to meals and hypoglycemia and then adjust insulin dosing in response to
these patterns in advance and help mitigate these problems. In this grant, we will explore how contextual
information may be used within an AID to help (1) avoid hypoglycemia and (2) reduce postprandial
dysglycemia. We will first conduct a data gathering study whereby we will collect a rich data set from people
with T1D who will use sensor augmented pump therapy to manage their glucose. Data will be collected from
these 30 patients over 28 days; data will include multivariable contextual information including continuous
glucose monitoring (CGM) data, insulin data, food data, physical activity data (heart rate and accelerometry),
as well as indoor/outdoor contextual movement patterns gathered using a novel beacon-based context-aware
sensing system called MotioWear developed by our group in collaboration with our industry partner MotioSens.
Next, we will utilize this contextual data set to construct a Bayesian glucose prediction algorithm. This will
include a clustering algorithm that will group contextual sequences that are similar with each other and which
lead to similar glycemic outcomes. This context-aware glucose prediction algorithm will be integrated into an
adaptive, personalized, smartwatch-based context-aware AID (CA-AID) system. Contextual patterns that have
a high likelihood of leading to hypoglycemia or postprandial dysglycemia will inform an insulin dosing
aggressiveness factor to be adjusted for similar contextual sequences observed in the future (i.e. the CA-AID
will reduce insulin for contextual sequences with high likelihood of hypoglycemia such as aerobic exercise). We
expect that integrating context awareness into an AID will lead to significant improvements in time in target
range during the day and will help reduce time in hypoglycemia. The CA-AID will be evaluated for safety in a
small pilot study. We will then evaluate the CA-AID within a 6 week clinical study in 40 adults with type 1
diabetes on insulin pump therapy. Twenty will receive the CA-AID while the other 20 will receive a standard
(non-context-aware) AID. The primary outcome measures of this study is the percent time in range. We
hypothesize that the CA-AID will increase time in range by 10% as compared with a non-context aware AID.

Public health relevance
Project Narrative Diabetes is the leading cause of blindness, kidney failure, and non-traumatic amputations. While automated insulin delivery systems can help people with type 1 diabetes better manage their glucose levels during the night, improved glycemic control during the day has not been demonstrated and hypoglycemia continues to be a problem, especially during exercise. We propose to develop and evaluate in a clinical study a context-aware automated insulin delivery system that learns patterns of daily living, meal patterns, glucose patterns, insulin dosing patterns, and physical activity patterns that relate to dysglycemia and adapts the gains within the AID to improve postprandial time in target range (70-180 mg/dL) and reduce hypoglycemia.